Immunologic and Neurodevelopmental Consequences of Neonatal Anemia and Thrombocytopenia and their Treatments

SUMMARY
The unifying theme of this PPG renewal is understanding the pathophysiology, and thereby establishing the
optimal management of two of the most frequently encountered hematologic conditions among critically ill,
premature infants: anemia and thrombocytopenia. Current treatment for these conditions relies largely on
transfusion of red blood cells and platelets, therapies that remain empiric, controversial and incompletely
investigated in this population. Prior studies by our PPG group and others have established that many aspects
of the pathophysiology of anemia and thrombocytopenia in premature infants are unique to this population.
However, our understanding of the consequences of this unique physiology in informing various treatment
strategies is incomplete. Importantly, studies from our group suggest that treatment approaches substantially
influence short- and long-term outcomes. Hence, the goals of our renewal are to define the unique
hematological features of preterm infants as they mature, the novel roles of red blood cells and platelets on
neonatal inflammation and immune regulation, and the consequences of neonatal anemia and its two
commonly utilized treatment strategies on neurodevelopment. Our 4 interrelated projects, whose objectives are
directly relevant to our unifying theme, include: Project 1 “Impact of thrombocytopenia and platelet transfusions
on neonatal inflammation and host defense,” PL Martha Sola-Visner; Project 2 “Impact of anemia on gut injury
and immune function in preterm infants,” PL Cassandra Josephson (and Sean Stowell); Project 3 “The effect of
neonatal anemia and its treatment on brain development,” PL Michael Georgieff; and Project 4 “The effect of
anemia and its treatment on neurodevelopmental outcomes of premature infants,” PL Peg Nopoulos. Core A
(“Administrative and data management core”) and Core B (“Biostatistical analysis and mathematical modeling
core,”) will provide support for all projects. Our goals will be achieved through a combination of human
clinical/translational studies and closely-matched animal models, in order to incorporate clinical and
mechanistic insights to better understand the developmental stage-specific effects of cytopenias and
transfusions in neonates. At our last renewal, and again in this submission, our PPG broke geographical
barriers to pursue the best possible combination of multidisciplinary scientists to achieve our goals. Our history
of success conducting multisite research will be invaluable in coordinating studies across the various
performance sites. Over the past 24 years, our PPG has made a substantial impact on clinical practice and
research in neonatal hematology and transfusion medicine. With this renewal, we are poised to continue to
challenge paradigms and advance knowledge, with the ultimate goal of improving the outcomes of our most
vulnerable patients.

Public health relevance
RELEVANCE The proposed studies will enhance our understanding of the effects of the two most important, common and costly hematological conditions encountered in the NICU: anemia and thrombocytopenia. Specifically, our research will determine the impact of different treatment strategies, particularly red cell and platelet transfusions, on critically important neonatal short- and long-term outcomes. Thus, these studies support the NIH's mission of reducing the burdens of illness and disability in our most vulnerable patients.